Mechanism of Herpes Simplex Virus (HSV) Induced Membrane Fusion

Herpesviruses are associated with a variety of disease in the human host, ranging from asymptomatic
infections to life threatening disease, including encephalitis and cancer. In addition to playing a direct role in
cancer genesis, herpesviruses pose an increased risk to cancer patients who may develop debilitating and life-
threatening herpesvirus infections. Genital herpes simplex virus (HSV) lesions, even if clinically not apparent,
can facilitate the transfer of HIV-infected cells or free virus from one individual to another, and HIV infection
and AIDS increase the risks of developing certain kinds of cancer. HSV-1 serves as a prototypic herpesvirus
family member and provides an ideal model to understand the requirements for virus infection since it
replicates well in cell culture and many reagents have been developed for its study. In particular, the study of
HSV-1 entry has proven useful in the understanding the mechanism of Epstein-Bar Virus (EBV)and Kaposi
Sarcoma Herpesvirus (KSHV) – two herpesviruses associated with cancer in human infections. Herpesvirus
entry into cells requires fusion of the outer envelope of the virus with a cell membrane. Spread of infection can
occur via infectious virus or virus-induced cell fusion. The ultimate objective of studies described here is to
understand how herpesviruses, specifically HSV-1, induce membrane fusion, the process required for viral
entry and cell fusion. Requirements for HSV-induced membrane fusion include the coordinated activities of
four HSV glycoproteins (gD, the hererodimeric gHgL complex, and gB) and specific cellular receptors. Our
central hypothesis is that gD, present in the viral envelope or on an infected cell surface, binds to a cellular
receptor, such as nectin-1, on an uninfected cell and activates gHgL and gB via protein-protein interactions,
resulting in fusion mediated by gB. In three aims, we plan to define the sequence requirements and domains of
gD, gH/gL and gB that are required to mediate membrane fusion and to investigate means to stabilize gB so
that prefusion gB can be studied. The results of these studies will lead to an understanding of the mechanism
of herpesvirus-induced membrane fusion and to new approaches for the prevention and treatment of
herpesvirus infections.

Public health relevance
Project Narrative This proposed research will further define the molecular mechanisms involved in herpesvirus infection using the prototypic human herpesvirus herpes simplex virus 1 (HSV-1). Herpesviruses cause significant disease and morbidity within the human population ranging from asymptomatic infections and blindness to life- threatening illness such as encephalitis and cancer. The proposed research may result in the identification of new prophylactics or therapeutics for herpesviruses that will lessen the pathologies associated with viral infection.